Associations among monoamines, tau pathology and emotional memory in aging

PROJECT SUMMARY
Major lines of Alzheimer’s Disease (AD) research focus on identifying the earliest AD-related pathologic changes
that occur in aging. One target of this research is monoamine-producing brainstem nuclei, where both the
noradrenergic locus coeruleus (LC) and the serotonergic dorsal raphe nucleus (DRN) are among the first regions
to accumulate abnormal tau, even in cognitively normal older adults. Despite the specific vulnerability of these
neuromodulator systems to tau pathology, there is little AD-focused research incorporating direct measures of
neuromodulator function in-vivo. Assessing the neurochemical health of these brainstem nuclei in the face of
age-related tau pathology may provide insight into the mechanisms differentiating individuals who remain
cognitively normal versus those who go on to develop AD. Previous postmortem neuropathology work has
examined age and AD-related changes in the LC and DRN, though there is currently little in vivo research which
has attempted this. This proposed research addresses this gap by using a combination of positron emission
tomography (PET) methods, [18F]Fluoro-m-tyrosine ([18F]FMT) and [18F]MK-6240. [18F]FMT has been recently
established as a promising PET tracer for measuring monoamine synthesis capacity in the LC and DRN
simultaneously. Given limitations of currently-developed tau-PET tracers, analyses of tau pathology will focus on
temporal lobe regions. The current proposal will define how tau pathology and monoamine synthesis capacity
relate to performance on an emotional memory task. A focus on interactions between memory and emotion is a
central component of the proposed research given the importance of monoamine systems in affective health and
the growing appreciation of AD-related affective dysregulation. Aim 1 will directly relate LC and DRN [18F]FMT
net tracer influx (Ki) with [18F]MK-6240 standard uptake value ratio (SUVR). Primary analyses will focus on both
the amygdala and Braak I/II [18F]MK-6240 SUVR, given these regions are structurally connected with both the
DRN and LC and have been implicated in negative emotional experience and memory. Aim 2 will examine how
DRN/LC [18F]FMT Ki and amygdala/Braak I/II [18F]MK-6240 SUVR relate to negative and neutral memory
performance. Secondary analyses in both aims will test for interactions with sex and beta-amyloid burden. This
proposal will provide the applicant with unique training in (1) the neuropathology of aging and preclinical
Alzheimer’s disease (2) the administration, processing, and analysis of both reversible and irreversible PET
tracers, (3) the best practices for developing and administering cognitive neuroscience tasks in older adult
populations, and in (4) oral and written communication and mentorship. Sponsors Dr. Anne Berry and Dr. Heidi
Jacobs have extensive backgrounds and success in these four domains and are located at institutions with
strong track records for training young scientists (Brandeis University and Massachusetts General Hospital,
respectively). This proposed project will help the applicant pursue a career in academic research focused on
defining the neural underpinnings of human behavior and the pathophysiology of neurodegenerative disease.

Public health relevance
PROJECT NARRATIVE Despite the accumulation of tau pathology in older adult populations, a large proportion of individuals maintain stable cognitive function and have better-than-expected trajectories. Characterizing factors that may contribute to resilience in the face of pathology could help guide the understanding of the pathophysiology of Alzheimer’s disease and could drive future research on targets for early therapeutic interventions. This proposed research will use cutting-edge neuroimaging methods in a cognitively normal older adult population to examine how brainstem neuromodulator systems relate to the accumulation of tau and accompanying affective and cognitive dysregulation.